Pathology and Bio-analytics Core

Overarching goal of the Center is to understand the mechanisms of pathophysiology of diabetes
and obesity and their cardiovascular complications. The Bioanalytics Core is an integral part of
the Center and will play a key role in the evolution of COBRE in Phase III. The Core will render
services for rigorous and comprehensive bioanalytical analysis of diabetic specimens. It will
provide intellectual input with experimental design and state-of-the-art technical expertise to
address the needs of Center investigators. The Core consists of a group of outstanding scientists
with expertise in chromatography, mass spectrometry, clinical chemistry, cardiovascular
physiology and diabetes. Director of the Core, Dr. Sanjay Srivastava has more than twenty five
years of research experience in analytical biochemistry and pathology, vascular inflammation,
atherosclerosis and diabetes. He will oversee all the Core operations and will work closely with
Center investigators and COBRE-supported pilot project leaders to fulfill their analytical
biochemistry needs. Dr. Lorkiewicz, technical director of the Core has extensive experience in
stable isotope labeling and mass spectrometric analyses of small molecular weight compounds.
He will assist the Center investigators with their metabolomics, mercapturomics and other
chromatography/mass spectrometry analyses. Drs. Srivastava and Lorkiewicz will provide hands
on training to junior investigators for bioanalytical assays. The training acquired at the Core will
facilitate them to grow as scientists and expand their repertoire of technical skills. The Core is
equipped with state-of-the-art clinical chemistry and analytical biochemistry equipment and is
located in the Delia Baxter Building. In addition to address the current requirements of the COBRE
projects, the Core will continue to expand its knowledgebase and technical expertise to satisfy
the future needs of the Center. Long term goal of the Core is to become a fiscally independent
entity capable of providing cutting-edge pathology and bio-analytical services to researchers
interested in diabetes and cardiovascular pathophysiology. Continued excellence in pathological
analyses will foster collaborations which will not only help the Core financially, but will also
advance the field in combatting diabetic complications.